Illuminating apical extracellular matrix structure and biogenesis

Apical extracellular matrices (aECMs) are associated with all epithelia and are essential for animal life.
They form an outer protective layer against biotic and abiotic (physical damage) challenges from the
environment. Human diseases associated with aECM dysfunction manifest a range of pathologies
including, but not limited to, fibrosis, osteoarthritis, and cancer. aECMs also play important structural roles
and are critical in mechanotransduction, such as in the vertebrate inner ear. However, in general we lack
an understanding of the 3D organization of aECM at a molecular level, including its dynamics in
development and disease states. The premise for this work is to create a systematic set of fluorescently
tagged endogenous apical extracellular matrix (aECM) components, and further, through characterization
using super-resolution microscopy, to reveal how these molecules are organized into nanoscale patterns in
vivo. aECMs are associated with all epithelia and are essential for animal life. A hallmark of aECMs is their
ability to form complex 3D structures patterned at the sub-micron scale. Such nanoscale architectures have
been described by electron microscopy in a variety of systems but have for the most part lacked molecular
correlates. Despite their recognized importance, the composition and biogenesis of aECMs remain poorly
understood, partly because many aspects of aECM biology can only be fully studied in vivo. Moreover, a
critical knowledge gap in aECM biology is how secreted molecules assemble in the extracellular
environment to form and maintain complex 3D structures with nanoscale patterning. Basic features of the
spatial and temporal localization of aECM components remain poorly understood because of these
challenges. The increasing tractability of gene editing technology has enabled tagging of endogenous
proteins (knockins); coupled with advanced imaging, knockin tagged proteins allow rigorous analysis of
aECM nanoscale structure and biogenesis. We will exploit these technical advances to develop a
standardized set of strains expressing fluorescently tagged aECM proteins in C. elegans, the ‘aECM
toolkit’. These reagents will not only reveal novel aspects of aECM biology but will also establish principles
for tagging and live imaging of the aECM in other systems. Our toolkit will open up the field of nanoscale
aECM patterning to molecular genetic dissection, as well as leading to enhanced understanding of aECM in
disease. We will generate a set of 100 knockin strains using CRISPR/Cas9 genome editing and make our
toolkit and protocols widely available, generating a critical resource for the community. We will determine
localization, biogenesis, and nanoscale architecture of aECM components. We will use live imaging to
determine how aECM components are secreted and assemble into complex 3D structures during
development. Our aECM toolkit will illuminate aECM assembly and dynamics and will fill critical knowledge
gaps in aECM structure and dynamics in development and diseases.

Public health relevance
PROJECT NARRATIVE Understanding how the material surrounding cells (“apical extracellular matrices”) are built and remodeled in living animals is a major challenge, relevant to human development and a wide range of human diseases. We are using the genetically tractable nematode C. elegans to tag a representative set of 100 apical extracellular matrix genes with fluorescent proteins, to allow super-resolution imaging of the extracellular matrix in living animals. This work will reveal previously unappreciated detail and complexity of extracellular matrix structure and function and will provide a unique resource for the community.